Ribosome structure determination from Apicomplexan parasites

PROJECT SUMMARY/ABSTRACT
The Apicomplexa phylum contains many parasites that infect and cause disease in humans and animals,
including the agents that cause malaria, toxoplasmosis, and babesiosis. Babesia is a tick-borne intracellular
parasite that causes severe to fatal diseases, with broadening geographic distribution because of climate change
and increasing suburban developments in forested areas. There is no vaccine against human babesiosis, and
the current therapies have limited efficacy. Considering the complex life cycle of Babesia species, their survival
depends on the precise control of their gene expression, which is mostly regulated post-transcriptionally (e.g.,
during protein synthesis). Babesia species have a unique, non-photosynthetic organelle named apicoplast,
derived from a secondary endosymbiotic event. In addition to having ribosomes in its cytoplasm and
mitochondria, the apicoplast contains its own ribosomes. Little is known about the structure of these ribosomes,
although they are thought to be highly simplified, with prokaryotic-like components. They are inhibited by
antibacterial drugs that have some limited antiparasitic activity. The absence of a molecular structure of any
apicoplast ribosomes limits the rational design of antibiotics with improved antiparasitic properties. In the first
aim of this research proposal, we will establish a Babesia divergens strain expressing an hemagglutinin (HA)-
tagged triose phosphate transporter on the outer membrane of the apicoplast. This strategy will allow the affinity
purification of a high-quality organelle preparation, followed by the purification of apicoplast ribosomes. In the
second aim, we will define the components of apicoplast ribosomes and determine their structure using cryo-
electron microscopy (cryo-EM). Our goal is thus to elucidate the fundamental molecular machinery that
apicomplexan parasites use to synthesize proteins in the highly specialized apicoplast organelle. Our work will
lay the foundation for studies that interrogate these parasites' gene regulation mechanisms and help inspire the
design of better antiparasitic agents.

Public health relevance
PROJECT NARRATIVE Babesia species are thick-borne intracellular parasites that infect the red blood cells of their mammalian host, causing severe to fatal diseases called babesiosis. Novel and effective drugs against Babesia parasites are needed, given its increasing worldwide distribution and the lack of a vaccine to treat this illness. This proposal aims to determine the structure of apicoplast ribosomes from B. divergens.